Michigan Prostate SPORE 2025-2030

Since its inception in 1995, the Michigan Prostate SPORE has harnessed the extensive intellectual and physical
resources of the University of Michigan (U-M) community to reduce the morbidity and mortality associated with
prostate cancer (PCa). The program supports an interactive group of basic and clinical investigators engaged in
translational research, leading to significant advancements in the diagnosis, prevention, and treatment of PCa.
Key achievements from the most recent grant period include: 1) Retrospective characterization of CDK12-
mutant PCa's clinical behavior (Eur. Urol., 2020) and completion of the IMPACT clinical trial assessing immune
checkpoint blockade in CDK12-altered metastatic PCa (Clin. Cancer Res., 2024). 2) Development of Cdk12
knockout mice (Cell Rep. Med., 2024) and CDK12/13 PROTAC degraders (J. Med. Chem., 2022) to investigate
the role of CDK12 in PCa. 3) Clinical validation of the urinary MyProstateScore 2.0 (MPS2) multiplex QRT-PCR
assay, based on TMPRSS2-ERG, PCA3, and 16 transcripts associated with aggressive PCa (JAMA Onc., 2024).
4) Development and evaluation of over 50 new androgen receptor (AR) PROTAC degraders (Neoplasia, 2020;
J. Med. Chem., 2021). These translational research efforts are bolstered by horizontal and vertical
collaborations with numerous institutions, resources, and biotech companies, including the University of
Washington, National Cancer Institute Early Detection Research Network, Michigan Urological Surgery
Improvement Collaborative, Canary PCa Active Surveillance Study, Lynx Dx, Esanik Therapeutics, RAAPTA
Therapeutics, and Aurigene Oncology. We also continue to partner with the Karmanos Cancer Institute (KCI) in
this application as a collaborating clinical site, allowing the SPORE to leverage the diverse patient populations
of both institutions, including an underserved demographic at KCI. This application introduces three new projects:
Project 1: Targeting PIKfyve-driven lipid homeostasis as a metabolic vulnerability in neuroendocrine PCa
(NEPC). Here we identify the lipid kinase PIKfyve as a therapeutic target for NEPC.
Project 2: Validation and clinical utility of a multiplex urine biomarker for identifying clinically significant PCa,
focusing on a clinical utility trial for MPS2.
Project 3: Development of serine/threonine phosphatase PP2A molecular glues for the treatment of
advanced PCa, creating first-in-class PP2A molecular glues for PCa.
These projects are supported by an ongoing institutional commitment of funding and space, successful Career
Development and Developmental Research Programs, and three cores: Administrative,
Biostatistics/Bioinformatics, and Biospecimen/Pathology. The Michigan Prostate SPORE continues to prioritize
rigorous scientific review of its translational research programs, the collaboration of basic and clinical
investigators, leveraging expertise from within and outside the PCa field, and maintaining flexibility to fund
promising new research approaches.

Public health relevance
The Michigan Prostate SPORE seeks to decrease the morbidity and mortality associated with prostate cancer by making scientific advances that address critical questions in prostate cancer tumorigenesis and treatment. In the Michigan Prostate SPORE renewal, three translational projects together identify and address major barriers and challenges that exist for the diagnosis and clinical management of prostate cancer and progression to metastatic disease. These projects are highly collaborative with respect to the multidisciplinary nature and expertise of the Co-Leaders.